Investigation of the role of TMED9 in the accumulation of a mutant protein in MUC1 kidney disease (MKD)

Abstract
Chronic kidney disease (CKD), most often caused by manifestations of systemic disease or underlying primary
kidney disease, is a significant cause of worldwide patient morbidity and mortality. The field of nephrology is
severely lacking in mechanism-based, targeted therapeutics to treat patients with CKD. Studies of primary, rare
genetic kidney diseases, which lead to perturbations of common, essential kidney processes, can be harnessed
to inform foundational kidney biology and identify potential therapeutic targets for kidney diseases, both rare and
common. MUC1 kidney disease (MKD), or autosomal dominant tubulointerstitial kidney disease-MUC1 (ADTKD-
MUC1), is a rare genetic kidney disease caused by a frameshift mutation in the MUC1 gene. MKD leads to
progressive kidney tubulointerstitial damage and eventual renal failure. Recent studies have shown that MKD is
a toxic proteinopathy in which the mutant frameshift protein, MUC1-fs, intracellularly accumulates in kidney
tubular epithelial cells and is associated with increased levels of cellular toxicity. MUC1-fs has been further shown
to accumulate specifically in the early secretory pathway of MKD patient kidney tubular epithelial cells (P cells),
in vesicles that contain the protein TMED9. Critically, it has been found that knockout of TMED9 ameliorates
MUC1-fs accumulation in P cells. TMED9 and MUC1-fs have been shown to additionally colocalize in both an in
vivo MKD mouse model and MKD patient-derived iPSC organoids. Recent work has shown that TMED9 co-
immunoprecipitates with MUC1-fs in P cells. Based on these observations, this proposed work aims to
investigate the following hypothesis: In the setting of MKD, TMED9 and its interactors halt the trafficking of
misfolded MUC1-fs and retain it in the early secretory pathway, leading to MUC1-fs accumulation and increased
cellular toxicity. In Aim 1, the effect of TMED9 on MUC1-fs trafficking through the early secretory pathway will
be assessed by knockout of TMED9 in P cells and mapping of MUC1-fs trafficking by inhibition of secretory
pathway branches and assessment of MUC1-fs reaccumulation. The role of TMED9 as a mediator of cellular
toxicity will be assessed by comparison of cellular toxicity, following treatment with the ER stress-inducer
thapsigargin, in P cells and TMED9 knockout P cells. In Aim 2, the TMED9 protein complex that mediates MUC1-
fs accumulation will be identified. First, interactors of TMED9 in P cells will be found using co-immunoprecipitation
and mass spectrometry. Then, TMED9 interactors necessary for MUC1-fs accumulation will be identified using
a CRISPR/Cas9 arrayed knockout screen. Finally, the binding of these necessary interactors to MUC1-fs will be
assessed. In Aim 3, the role of TMED9 in MUC1-fs accumulation will be explored in vivo. A TMED9 knockout
mouse will be crossed with the established MKD knock-in mouse and the in vivo effect of TMED9 knockout on
MUC1-fs accumulation and other known MKD knock-in mouse phenotypes will be assessed.

Public health relevance
Project Narrative The proposed research will investigate the role of the early secretory pathway protein TMED9 in the accumulation of a mutant protein, MUC1-fs, in the toxic proteinopathy MUC1 Kidney Disease (MKD). Understanding protein accumulation in this rare genetic kidney disease may identify new therapeutic targets for this toxic proteinopathy, other toxic proteinopathies, and more common kidney pathologies that lack therapeutic solutions. Further, elucidation of the mechanism of MUC1-fs accumulation in MKD will provide insight into general mechanisms of proteostasis and kidney biology in health and disease.